IMMUNOLOGIC STUDIES OF HUMAN T-CELL LYMPHOMA VIRUS

HTLV-I is thought to be directly involved in malignant transformation of cells in adult T-cell leukemia and indirectly associated with other malignancies, myelopathies, neurologic disease (TSP/HAM), and chronic cutaneous infections in children. Studies are underway to examine the mechanism whereby the same virus appears to contribute to different types of diseases. Peripheral blood lymphocytes from HTLV-I seropositive individuals have been shown to undergo spontaneous proliferation when placed in culture. The levels of proliferation have shown some associa- tion with the diseased states and thus have been interpreted as reflecting viral activity in vivo. We have undertaken experiments to determine the nature of the lymphocyte population that is infected and the mechanism whereby spontaneous proliferation is induced. Lymphocytes from HTLV-I- infected and noninfected individuals were tested prior to and after 6 days of culture for cell-surface markers, cell activation, virus and cytokine production. Cells were separated on the basis of their surface markers and examined for proviral sequence and virus expression. CD4+ lymphocytes expressing the activation markers, HLA-DR and CD25, increased marginally in cultured cells from infected individuals. In cultures containing HLTV- I-infected cells 3H-thymidine incorporation and virus production increased with and without the addition of mitogens and cytokines. Antibodies that react with cell surface molecules that regulate lymphocyte activation and antisera that identifies viral proteins were added to the cultures. CD4+ and not CD8+ cells contained and expressed virus. Antibodies to the alpha/beta T-cell receptors activated the T-cells from HTLV-I-infected individuals. Activation of cells could be reversed by the addition of antibodies to MHC class I antigens and beta2 microglobulin as well as cyclosporin A. A patient infected with HTLV-II was diagnosed as having large granulocytic leukemia by cell surface marker studies. The expanded cell population was isolated by flow cytometry as was CD4+ and CD8+ cell populations. DNA and RNA were prepared from these cells and viral integration and expression determined.